PSYCHOSOCIAL/BEHAVIORAL/PHYSIOLOGICAL CHARACTERISTICS OF LONELINESS

Loneliness is a major risk factor for morbidity and mortality from widely varying causes, even controlling for known biological risk factors, social status, and baseline measures of health. The mechanisms underlying the relationship between social factors and health are not yet understood, but several different mechanisms are likely involved. To explore these mechanisms, this study is investigating the effects of loneliness and social embeddedness on psychological, behavioral, physiological, and health-outcome variables.